The Native American Short-Term Research Education Program in Children's Health Supplemental Proposal for additional Exceptional Mentoring Experiences

NARI-NHLBI DOSI SUPPLEMENTAL ABSTRACT
The American Indian/Alaska Native (AI/AN) populations are facing a health crisis that exceeds every
other underrepresented, underserved community in the US. Health disparities in AI/AN communities
exist throughout the lifespan. Eliminating health disparities, requires the identification, recruitment,
education, and training of the most talented scientists in the U.S. To increase AI/AN representation in
the biomedical workforce, we established a Native American Research Internship (NARI) program in
2010. Our holistic and comprehensive NARI program was developed to support AI/AN students, who
are underrepresented and underserved in both higher education and healthcare. Underrepresented
minorities are more likely to work with underserved populations and racial concordance between a
patient and clinician is associated with improved health outcomes. Our ultimate goal is to increase
AI/AN representation and leadership in science and medicine. To date, 171 NARI graduates
representing 62 tribal nations, 74 colleges/universities, and 29 home states have participated in the
program with 100% of participants either completing a college degree or in the process of completing
a degree, and no one has dropped out of college. Upon obtaining their undergraduate degree, 78
(60%) have continued their education in the health/science fields: 43 NARI participants were
accepted into a graduate program; 33 NARI were accepted into medical school and 2 were accepted
to a MD/PhD program. Thirteen are current medical residents and several have returned as leaders
in tribal communities; physicians, public health workers, pharmacists, etc. With these outstanding
outcomes, we begin to address our overarching goal of increasing AI/AN representation as leaders in
biomedical science regionally and nationally. Although the NARI program has been successful and
many NARI-NHLBI alumni have remained connected through social media, conferences and
friendship, we have identified several missed opportunities of NARI mentorship which we hope to
support with this supplemental grant: 1) Support mentoring activities across NARI cohorts during the
summer 2) Support NARI “near peer” and “peer to peer” mentoring activities outside of the NARI
summer program 3) MCAT prep financial support, and 4) Support NARI-NHLBI alumni interested in
shadowing and volunteer activities in tribal communities. Using the foundation of the NARI program,
we hope to support these unique opportunities and continue to grow meaningful national NARI
connections and regional connections.

Public health relevance
PROJECT NARRATIVE NARI program has been successful and many NARI-NHLBI alumni have remained connected through social media, conferences and friendship. We have identified several missed opportunities of NARI mentorship which we hope to support with this supplemental grant. Using the foundation of the NARI program, we aim to support “Near to Pear” and “Peer to Peer” mentoring opportunities and continue to grow meaningful regional and national NARI networking connections long after the conclusion of the summer program.